Human Alcohol Seeking Despite Aversion

Project Summary: Human Alcohol Seeking Despite Aversion
Prolonged alcohol use results in neuroadaptations leading to decreased sensitivity to alcohol, a shift from
positive to negative reinforcement-based alcohol use, increased negative affect that drives further
consumption, and, ultimately, aversion-resistant drinking. Aversion resistant drinking is a hallmark of more
severe and treatment-resistant persistent alcohol use. It has been widely studied in animal models, but has
not been well characterized in humans. This project aims to develop an objective measure of aversion resistant
drinking in humans, modeled as alcohol self-administration despite aversion, and to characterize its underlying
neural signatures. The positive impact of this project will be to advance the translation between preclinical
models and clinical models, and to elucidate distinct mechanisms underlying alcohol use disorder progression
in humans.